Predicting Migraine Attack Onset with Real-Time Individualized Autonomic Patterns

ABSTRACT
Current migraine management lacks objective tools for predicting imminent migraine attacks, which could
enable preemptive treatment and improved patient outcomes. This project aims to establish predictive
measures of migraine onset through continuous monitoring of autonomic activity using wrist-worn devices in
individuals with episodic migraine. Approximately 30-40% of migraine sufferers experience prodromal
symptoms, yet the mechanisms and temporal dynamics of these symptoms are poorly understood. Advances
in wearable sensor technology provide an opportunity to monitor physiological parameters correlated with
these symptoms continuously. We will exploit these advancements to test specific hypotheses through the
following aims: Aim 1: Identify predictive markers of migraine onset by analyzing continuous physiological data
(e.g., skin conductance, blood volume pulse, motion, skin temperature) from 60 patients using wrist-worn
sensors. Aim 2: Differentiate objective versus subjective evaluative measures to enhance prediction accuracy
of migraine onset. We hypothesize that autonomic changes will be detectable hours before an attack and that
combined objective and subjective data will yield robust predictive markers. The methodology includes
noninvasive, continuous data collection and transmission, complemented by self-reported data on prodromal
symptoms and migraine events via validated e-diaries. Utilizing machine learning, we will develop algorithms to
forecast migraine onset, enhancing the timing and efficacy of prophylactic treatments. This research leverages
existing technology validated for clinical use and promises to elucidate the pathophysiology of migraine
prodromes, offering transformative potential for migraine management.

Public health relevance
NARRATIVE This study aims to predict the onset of migraines by using wearable devices that continuously monitor biological changes like skin conductance and heart rate. By identifying early warning signs and combining them with patient-reported symptoms, we hope to develop a reliable method to alert patients before a migraine starts. This could enable timely medication use and significantly reduce the impact of migraines.